Mitochondrial chaperones mortalin and Tid1 in protein degradation

DESCRIPTION (provided by applicant): Protein misfolding and aggregation are associated with aging, as well as a variety of human diseases, including Parkinson's disease, cystic fibrosis, amyotrophic lateral sclerosis (ALS), short chain acyl-CoA dehydrogenase (SCAD) deficiency and hypertrophic cardiomyopathy. Mitochondrial proteins are at increased risk of protein misfolding and aggregation as they are located in proximity to the respiratory chain, which is a powerful source of reactive oxygen species (ROS). When exposed to elevated ROS, mitochondrial proteins are highly susceptible to oxidative damage and conformational defects. The surveillance system that oversees mitochondrial protein quality control is composed of ATP-dependent proteases, which degrade misfolded and damaged proteins, as well as molecular chaperones, which mediate protein folding and facilitate protein degradation. Within the mitochondrial matrix, the ATP-dependent proteases Lon and ClpXP selectively degrade normal and abnormal proteins in response to metabolic demands and changing environmental conditions. The matrix chaperones Mortalin and Tid1, function in concert to fold nascent polypeptides and to assist Lon- and ClpXP- mediated proteolysis. Interestingly, our preliminary results show for the first time, that Mortalin and Tid1 also mediate protein disaggregation. The aims of this project are- (1) to elucidate the functions of Mortalin and Tid1 in protein disaggregation, reactivation and refolding, as well as the interplay between these chaperones and the mitochondrial ATP-dependent proteases Lon and ClpXP; (2) to identify endogenous mitochondrial substrates of these proteases and chaperones. We hypothesize that mitochondrial quality control proteases and chaperones function to- (a) prevent the toxic accumulation of abnormal proteins, (b) facilitate the degradation of non-native polypeptides and (c) reactivate the functional state of proteins once they are disaggregated. Our research strategy is to develop and optimize biochemical and cell culture assays to study chaperone-mediated protein disaggregation, reactivation/refolding and degradation of reporter substrates. For example, a purified protein system will be employed to study Mortalin- and Tid1- dependent disaggregation and reactivation of insoluble and enzymatically inactive glucose-6-phosphate dehydrogenase (aggG6PDH); whereas denatured luciferase (unfoldedLuc) will be used to examine chaperone-assisted refolding. In addition, the interplay between Mortalin, Tid1 and mitochondrial proteases in protein degradation of an aggregation-prone mutant of ornithine transcarbamylase (aggOTC) will be carried out in cell culture experiments using knockdown cell lines for Tid1, Lon or ClpP, as well as with purified chaperones, proteases and aggOTC. Lastly, a proteomics approach will be undertaken to identify endogenous mitochondrial substrates of Tid1, Lon and ClpP. Mitochondrial proteins that accumulate or aggregate upon depletion of Lon, ClpP or Tid1 are likely to be substrates of these quality control proteins. Electron microscopy data show the accumulation of inclusion bodies within mitochondria of Lon-depleted cells. We predict a similar phenotype in ClpP- or Tid1- depleted mitochondria. Taken together, the results obtained from this project will provide the knowledge and experimental assays needed to elucidate further and exploit the protein quality control function of these mitochondrial chaperones and proteases in the management or treatment of protein-misfolding diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE: The aims of this R21 project are to elucidate the functions of the mitochondrial chaperones mortalin and Tid1 in protein disaggregation, refolding and reactivation, as well as their cooperative function with the mitochondrial ATP-dependent proteases Lon and ClpXP. In addition, we aim to identify endogenous mitochondrial substrates of these proteases and chaperones. The results obtained from this project will directly contribute to expanding current knowledge and experimental tools required to elucidate and exploit the function of these quality control proteins in protein misfolding and aggregation diseases such as- Parkinson's and Alzheimer's disease, cystic fibrosis, amyotrophic lateral sclerosis (ALS), short chain acyl-CoA dehydrogenase (SCAD) deficiency and hypertrophic cardiomyopathy. The aims of this R21 project are to elucidate the functions of the mitochondrial chaperones mortalin and Tid1 in protein disaggregation, refolding and reactivation, as well as their cooperative function with the mitochondrial ATP-dependent proteases Lon and ClpXP. In addition, we aim to identify endogenous mitochondrial substrates of these proteases and chaperones. The results obtained from this project will directly contribute to expanding current knowledge and experimental tools required to elucidate and exploit the function of these quality control proteins in protein misfolding and aggregation diseases such as- Parkinson's and Alzheimer's disease, cystic fibrosis, amyotrophic lateral sclerosis (ALS), short chain acyl-CoA dehydrogenase (SCAD) deficiency and hypertrophic cardiomyopathy. __SpecificAimsTextDelimiter__ SPECIFIC AIMS. Mitochondria are the principal source of reactive oxygen species (ROS), which are generated at increased levels during the progression of age-related disorders and a variety of human diseases. When exposed to elevated ROS, mitochondrial proteins are highly susceptible to oxidative damage and misfolding. Protein misfolding and aggregation are directly linked to disorders such as Parkinson's disease, amyotrophic lateral sclerosis (ALS), short chain acyl-CoA dehydrogenase (SCAD) deficiency and hypertrophic cardiomyopathy 1-3,32,33. The surveillance system that oversees mitochondrial protein quality control is composed of ATP-dependent proteases, which degrade abnormal and damaged proteins, as well as molecular chaperones, which mediate correct protein folding and facilitate protein degradation. Within the mitochondrial matrix the ATP-dependent proteases Lon and ClpXP selectively degrade both normal and abnormal proteins as a result of changing environmental conditions or metabolic demands 4. The mitochondrial matrix chaperones mortalin, Tid1 and Mge1, function in concert to promote the folding of nascent polypeptides, and to assist Lon and ClpXP in the degradation of misfolded proteins. In addition, our preliminary results show for the first time, that mortalin, Tid1 and Mge1 also mediate protein disaggregation. We hypothesize that the protease and disaggregase activities of these quality control proteases and chaperones function to- (1) prevent the toxic accumulation of abnormal proteins, (2) facilitate the degradation of non-native polypeptides and (3) reactivate the folded state of the protein after disaggregation. The goals of this R21 project are: Aim 1. To analyze the remodeling activity of mortalin and Tid1 in protein disaggregation, reactivation and degradation using biochemical and cell culture assays. Heat-shock protein (Hsp) family members Hsp70 and Hsp40 are the most highly conserved chaperones, present in bacteria, archaea and almost every compartment of eukaryotic cells 5. Mortalin and Tid1 are human mitochondrial homologs of Hsp70 and Hp40, respectively. We have shown that Tid1 is a conserved mitochondrial chaperone as it substitutes for the well-characterized mitochondrial homolog in yeast 6. Our preliminary data show that mortalin and Tid1 mediate the disaggregation and reactivation of preformed aggregates of glucose-6- phosphate dehygrogenase (aggG6PDH). In Aim 1, biochemical experiments using purified proteins will be used to measure chaperone-mediated remodeling and reactivation of heterologous reporters such as aggG6PDH and unfolded luciferase (unfoldedLuc). In parallel, cell culture experiments, will analyze Tid1-, ClpP- and Lon- dependent remodeling and degradation of an aggregation-prone mutant of mitochondrial ornithine transcarbamylase (aggOTC). Using purified proteins, we will also determine the requirement for mortalin, Tid1 and Mge1 in the proteolytic breakdown of aggOTC by Lon and ClpXP. Expected outcomes. The results obtained from these experiments will fill a large knowledge gap about the role of the human mitochondrial chaperones mortalin and Tid1 in protein disaggregation, reactivation/refolding and degradation. The biochemical and cell culture assays established in this study will be the basis for future projects aimed at developing high throughput screens for identifying small molecules that activate or inhibit the chaperone function(s) of mortalin and/or Tid1. Such chemical tools will allow us to characterize and understand the function of these chaperones in human health and disease. Aim 2. To identify endogenous mitochondrial substrates of Tid1, ClpXP and Lon. Although the cooperation between ATP-dependent proteases and chaperones is well established in bacteria and yeast, little is known about the interplay between these quality control proteins in human mitochondria. Tid1, ClpXP and Lon exhibit fundamentally distinct roles in the cellular response to stress and environmental adaptation. For example, ClpP and Tid1 expression are induced by unfolded proteins mitochondria, whereas Lon expression is unchanged 7-9. By contrast, Lon expression is upregulated by unfolded proteins within the endoplasmic reticulum (ER) and is involved in the response to ER stress and hypoxia 10,11. Using stable cell lines permitting the knockdown of Tid1, ClpP or Lon, we will undertake a proteomics approach to identify mitochondrial proteins that accumulate or aggregate upon depletion of these chaperone/proteases. Such proteins are likely substrates of Tid1, ClpP and Lon. As our electron microscopy data show an accumulation of inclusion bodies within mitochondria of Lon-depleted cells (see Fig. 6), we predict a similar phenotype in Tid1 and ClpP-depleted mitochondria. To further augment protein aggregation, knockdown cells will also be subject to hypoxia, mitochondrial- or ER- stress. Expected outcomes. Our goal is to identify the unique and overlapping protein substrates of Tid1, ClpP and Lon, in the presence and absence of physiological stresses. As discussed in the Significance section below, we hypothesize that mitochondrial ATP-dependent proteases and chaperones are potential and novel anti-cancer drugs targets that promote mitochondrial protein aggregation and dysfunction resulting in apoptosis. Knowing the target substrates of Tid1, ClpP and Lon will assist us in testing this hypothesis in the future, and will provide physiological insight into the pathways governed by these quality control proteins.